Project 2: Combined personal neoantigen-targeting cancer vaccines with immune checkpoint blockade for ovarian cancer

Project Summary
Although epithelial ovarian cancer (EOC) is initially a chemosensitive disease, it is infrequently cured by
standard-of-care (SOC) platinum-based chemotherapy. Given the abundant evidence indicating that ovarian
tumors are immunogenic, several immunotherapy approaches have been previously evaluated in this disease
but without evidence of potent anti-tumor immunity or clinical activity. Immune checkpoint blockade (CPB)
therapy, which has revolutionized treatment of multiple cancers, has demonstrated only modest effectiveness in
EOC, highlighting the urgent need of new strategies to extend the benefit of CPB in this disease. Over recent
years, we have developed new computational tools to identify immunogenic candidate patient-specific mutated
epitopes (also called neoantigens) that are capable of stimulating tumor-specific T cell responses. Advances in
prediction algorithms generated by our team now provide opportunities for studying the feasibility of generating
neoantigen vaccines in tumors with intermediate mutation load (Abelin Immunity 2017), such as EOC, and for
the testing of how the vaccine can be administered in conjunction with SOC therapy. This promising activity has
led us to prospectively test the targeting of personal neopeptides as cancer vaccines, and we have demonstrated
the safety, feasibility and immunologic activity of immunizing patients with advanced melanoma (Ott, Nature
2017) and glioblastoma (Keskin, Nature 2019) with personal vaccines consisting of up to 20 mutated epitopes
per patient, delivered as synthetic long peptides (20-30mers) admixed with the potent immune adjuvant poly-
ICLC, a TLR3 agonist (called ‘Neovax’). In these proof-of-concept studies, some of the induced neoantigen-
specific T cell responses could recognize autologous tumor cells. Moreover, complete responses with sustained
remissions were observed in patients when anti-PD1 therapy was administered in addition to neoantigen
vaccine. Based on these promising results, we now propose to evaluate, in a new clinical trial, the combined
administration of personal neoantigen-targeted cancer vaccines together with CPB therapy for low residual
volume EOC. We hypothesize that this approach will effectively expand existing tumor-reactive T-cells and
broaden the T-cell repertoire to include new tumor-specific T-cells and thereby generating highly specific anti-
tumor immunity with fewer autoimmune side effects. We will evaluate the feasibility and safety of Neovax in
combination with nivolumab in EOC (Aim 1). Through integrated characterization of circulating blood immune
responses with in situ changes in the tumor and tumor-infiltrating immune cells at serial time points across the
course of therapy, including in the event of disease progression, we seek to elucidate candidate mechanisms of
response and non-response to vaccine and CPB therapy (Aims 2 and 3).

Public health relevance
Project Narrative Checkpoint blockade monotherapy exhibits only modest activity against ovarian cancer. Building on our ability to identify cancer determinants that can be recognized by the immune system (so-called ‘antigens’) from patient tumors, including from ovarian cancer, that are optimal because they are expressed only on tumor cells (and not normal cells) and are highly immunostimulatory, and based on promising data supporting new cancer vaccination efforts to target these personal tumor antigens that may synergize effectively with checkpoint blockade therapy, this proposal aims to investigate the therapeutic potential and biologic activity of this novel immunotherapy strategy for ovarian cancer.